The role of NPM1 in preserving a hematopoietic stem cell identity

NPM1 gene mutations are considered driver mutations in the pathogenesis of acute myeloid leukemia (AML).
Nucleophosmin (NPM1) belongs to the nucleophosmin/nucleoplasmin (NPM) family of nuclear chaperones, of
which there are three genes: NPM1, NPM2 (nucleoplasmin), and NPM3, whose protein functions include
chromatin remodeling, genome stability, ribosome biogenesis, and embryogenesis. In humans, NPM1 has
three isoforms of which isoform 1 is the predominant type and is the only one expressed in mouse. My
postdoctoral studies focused on a fundamental epigenetic feature involving the local recycling of parental
nucleosomes, which showed that repressed, but not active, chromatin domains are inherited. While attempting
to identify a histone chaperone(s) that facilitates the inheritance of repressed chromatin domains in mouse
embryonic stem cells (mESCs), I discovered that NPM1 plays an essential role in this process (preliminary
data). While the role of NPM1 in the cell has been well characterized, its function in normal hematopoiesis
remains unknown.
With regard to hematopoietic stem cells (HSCs), the epigenome confers self-renewal and differentiation
functions wherein inheritance of HSC chromatin states is persistent across cell cycles. In this proposal, we will
identify the molecular basis of NPM1 in constructing the heritable epigenome of HSCs and determine whether
aberrant function in this process contributes to the etiology of NPM1-driven cancer mutations. As species-
specific differences exist between mouse and human NPM1 biology, we propose to complement human and
mouse NPM1 biology utilizing in vitro human and in vivo mouse HSC differentiation systems. These systems
include in vitro human induced Pluripotent Stem Cells (iPSCs) to differentiate and derive a hematopoietic
progenitor cell (HPC) fate and developing an Auxin-induced degron (AID) mouse model for NPM1 to deplete
NPM1 protein in vivo in a targeted and regulated manner in HSCs. Integrating human iPSC technology with an
AID mouse model for NPM1 has the potential to set a precedent in assessing the function of essential genes
that are frequently mutated in disease. In this instance, identifying NPM1 mediated chromatin mechanisms
necessary for constructing the heritable epigenome of HSCs and its aberrant function in leukemia.

Public health relevance
Although adult acute myeloid leukemia (AML) carrying Nucleophosmin (NPM1) mutations constitute ~35% of all cases, little is known regarding NPM1 functions in normal hematopoietic stem cell (HSC) development. My investigation of NPM1 in mouse embryonic stem cells (mESCs) shows a role for NPM1 in the epigenetic inheritance of repressed chromatin domains. In this proposal, we will identify the molecular basis of NPM1 in constructing the heritable epigenome of HSCs and determine whether aberrant function in this process contributes to the etiology of NPM1-driven cancer mutations.